MODULATION OF LH SECRETION BY MELATONIN IN YOUNG WOMEN

The purpose of this study is to characterize the effects of a melatonin infusion on reproductive hormone secretion, and to determine if these effects change with weight loss.